Using Multimodal Clinical and SDOH Data to Develop Risk Models for Predicting Severe Maternal Morbidity

PROJECT ABSTRACT
Severe maternal morbidity (SMM) is defined as an unexpected adverse outcome during pregnancy or
postpartum (PP) with significant short- or long-term negative consequences to a woman’s health. Rates of
SMM have risen substantially in the past decades and are >50% higher for non-Hispanic Black women than
non-Hispanic White women. Leading causes of SMM and associated deaths are preventable and result, in
part, from a systems-level failure to recognize and manage the co-occurring physical, mental, and social risk
factors that women experience across the perinatal, intrapartum, and PP periods. Adequate prenatal care and
appropriate management of chronic conditions during pregnancy may mitigate rising maternal risk. However,
important knowledge gaps limit efforts to improve and optimize care. First, clinicians and health systems are
limited in predicting patients who will be most likely to have complications such as SMM. Second, social
determinants of health (SDOH), defined as, conditions in the places where people live, learn, work, and play
that affect a wide range of health and quality-of life-risks and outcomes, may be an important determinant of
outcome disparities and inadequate prenatal care. However, SDOH may be sub-optimally captured by using
routine screening questions during patient encounters and population-level exposures. We propose addressing
these critical knowledge gaps by leveraging highly granular, longitudinal clinical data linked with SDOH data
derived from the Patient-Centered Outcomes Research Institute (PCORI)-funded INSIGHT Clinical Research
Network (Co-PI Pathak) on >365,000 women across New York City (NYC). In Aim 1, we will link longitudinal
electronic health records (EHRs) and claims data and characterize the study cohort. We will also ascertain
community- and individual-level measures of SDOH by linking population-level SDOH data for the study cohort
using natural language processing (NLP) and machine learning (ML) methods from clinical note narratives. In
Aim 2, we will predict the risk of SMM, as well as assess fairness and bias through ML models. Our rich multi-
level data, measurement, and analytical approach will apply ML models to analyze EHRs and
community/neighborhood- and individual-level SDOH data, and ascertain key drivers and predictors of SMM
risk. In Aim 3, we will collaborate with the recently established NICHD U54 center to study the clinical
interpretability and actionability of ML-based risk models for SMM. Findings from this aim will provide
actionable recommendations in future risk score implementation efforts using point-of-care clinical decision
support tools.

Public health relevance
PROJECT NARRATIVE Severe maternal morbidity (SMM) has increased substantially over recent decades across the US. This project will leverage large-scale, longitudinal multimodal electronic health records and social determinants of health data to develop risk models for predicting SMM using novel machine learning methods.